Elucidating the role of reactive nitrogen species in bacterial interactions

Project Summary/Abstract
Most bacteria are found living within complex polymicrobial environments where they must compete for
nutrients, space, oxygen, and defend themselves against exogenous, host, or bacterial derived antimicrobials.
Bacterial community dynamics and behavior can be greatly influenced by reactive nitrogen species (RNS),
which are important signaling molecules, immune mediators, and antimicrobials. Unfortunately, there is limited
understanding on how RNS regulate the structure and function of polymicrobial communities and what impact
this interplay has on host immunity, which has created enormous gaps in knowledge. Previous studies that
explore the role of RNS on microbial physiology predominantly use single species models instead of
polymicrobial models, which better represent the lifestyle of microbes. Our preliminary findings indicate that
commensal or beneficial bacteria induce the production of RNS to outcompete pathogenic bacteria and
maintain homeostasis within a host. Yet, there are no studies that have clearly defined the molecular
mechanisms that govern synergy between commensal bacteria and RNS, and how they dictate the pathogen-
host relationship. Over the next five years, the studies outlined in this MIRA application will use molecular
genetics, systems biology tools (metabolomics, proteomics, and RNA sequencing), and a Drosophila
melanogaster invertebrate model to determine how RNS regulate interactions between commensals and
pathogens and also elucidate what impact this has on the host. Critically the field of RNS as an effector of
bacterial population dynamics is vastly understudied yet is vital to understand because it has significant health
consequences. The findings of this research proposal will advance the field of bacterial-bacterial interactions,
as well as the role of RNS responses in controlling and modulating the host-pathogen interface. Our studies
could potentially provide valuable mechanistic data that can be harnessed for the development of commensal-
mediated anti-infection therapies.

Public health relevance
Project Narrative Interactions within bacterial communities are highly regulated by microbial, host, and environmental factors, and these interactions have a significant role in microbial competition and the host response. Reactive nitrogen species (RNS) derived from microbes plays a significant role in the behavior and function of mixed species communities. Using molecular genetics, systems biology tools, and a Drosophila melanogaster model our mechanistic studies will increase our understanding about how RNS production within polymicrobial communities drives bacterial competition and the host response to microbes.